Pregnancy Risk Assessment Monitoring System (PRAMS)RFA-DP-16-001

Washington State PRAMS Core Grant –Component A Project Summary/Abstract PRAMS 2016 Grant Project Title: Pregnancy Risk Assessment Monitoring System (PRAMS) (U01) Category B. (Existing States) Washington State PRAMS 2016 Project Director: Riley Peters, PhD, Address: Washington State Department of Health PO Box 47835 Olympia, WA 98504-7835 (360) 236-3581 Project Period: May 5, 2016 to April 30, 2021 The overall goal of Washington Pregnancy Risk Assessment Monitoring System (PRAMS) is: To provide data to help develop and evaluate prevention and control measures, research strategies, and policy options aimed at improving the health of women, infants and families in Washington State. Survey participants, approximately 1,800 per year, are drawn from birth certificate data using a stratified random selection based on race/ethnicity. The data collection method for Washington PRAMS involves a statewide mailing of the questionnaire with telephone follow-up for non-responders. Current aims are: 1) The Washington State PRAMS Project will survey 1,800 recent mothers annually. 2) The Washington State PRAMS project will analyze, interpret, and disseminate PRAMS data. 3) The Washington State PRAMS project will utilize PRAMS data to plan and monitor programs and policies aimed at reducing health problems among mothers and infants.

Public health relevance
Washington State PRAMS Core Grant –Component A Project Narrative The overall goal of Washington Pregnancy Risk Assessment Monitoring System (PRAMS) is to provide data that will influence program strategies, and policies that impact the health of women, infants and families in Washington State. The PRAMS survey provides a unique source of data on the behaviors and experiences of women before, during and just after delivery that is not available from any other source at the state level. This purpose of this proposal is to continue the PRAMs survey in Washington State. Approximately 1,800 Washington resident mothers per year are drawn from birth certificate data using a stratified random selection based on race/ethnicity. With a response rate of approximately 68%, we are expecting that 1,200 women will participate in the survey. The data collection method for Washington PRAMS will involves a statewide mailing of the questionnaire with either a telephone or web-based survey as follow-up for non-responders. Completed surveys are cleaned by CDC, linked to the annual birth certificate file and weighted for non-response, an analytic file is sent to Washington PRAMS. Once Washington State receives the final analytic file from CDC we will analyze, interpret, and disseminate PRAMS data. The Washington State PRAMS project will utilize PRAMS data to plan and monitor programs and policies aimed at reducing health problems among mothers and infants.